Data Management and Analysis Core

PROJECT SUMMARY (Data Management and Analysis Core: Lemos, Swetnam, Merchant)
The University of Arizona Superfund Research Program (UA SRP) will generate volumes and types of data that
are not manageable in typical laboratory settings. The Data Management and Analysis Core (DMAC) will function
as the primary service for UA SRP data management and analysis of large biological, geophysical, and chemical
datasets, including but not limited to bulk and single cell RNA sequencing, geospatial coordinates and
geochemical composition, analytical chemistry, and imaging. DMAC enables investigators by performing three
core functions: (i) DMAC will lead the housing of all data in an easy-to-access data repository system: CyVerse.
Cyverse is a computational infrastructure consisting of hardware, software, and personnel that are designed to
handle huge datasets and complex analyses, and is maintained at the University of Arizona. DMAC will utilize a
reference implementation (RI) that divides data into five different levels for easy data sharing, processing, and
analyzing. Lowest levels (level 1) will be raw data, while higher levels (level 5) will be file formats utilizable in
graphics visualizations. DMAC will support these processes with help from on-staff data analysts and
bioinformaticians as well as CyVerse programmers who can devise analysis strategies for individual
investigators. In addition to data storage, DMAC will orchestrate sample management using Fulcrum software.
Fulcrum allows barcoding, global positioning, and annotation of biological samples in an easy-to-use application
available on both traditional workstations and mobile platforms. (ii) Beyond data and sample management,
DMAC will perform both standard and custom computational processing and analyses of data. In conjunction
with UA SRP investigators, DMAC will apply traditional algorithms, or develop novel algorithms as needed, to
identify signatures for the different data types collected. (iii) The storage and analytical capabilities of DMAC will
be integrated into user-friendly web applications that allow individual investigators to retrieve, manipulate, and
visualize UA SRP data. The web application will be implemented using an in-house maintained server in
conjunction with the R statistical environment. DMAC is thus an integral component of the UA SRP proposal that
utilizes state-of-the-art technologies to enable effective data management and the discovery of novel insights
into arsenic exposure and its role in health and disease.

Public health relevance
PROJECT NARRATIVE (Data Management and Analysis Core: Lemos, Swetnam, Merchant) Understanding the roles of arsenic containing airborne dust particles in complex diseases and lung dysfunction requires an integrated approach that combines vast quantities of information from multiple fields, including biomedical science, geology, chemistry, as well as environmental science and engineering. The Data Management and Analysis Core serves as the primary storage and analytical service for the data generated from various experiments investigating arsenic exposure, toxicity, and mitigation. DMAC builds upon the CyVerse infrastructure and utilizes state-of-the-art hardware, software, and analytics to merge the findings of various scientific disciplines into new insights.